Multimeric Structural Degradation of vWF in Turbulent Flows

ABSTRACT
Acquired von Willebrand Syndrome (AvWS) characterized by the loss of high molecular weight multimers
(HMWMs) of von Willebrand factor (vWF) is often associated with nonphysiologic blood flows. AvWS is
found in patients with severe aortic stenosis (AS) or continuous-flow left ventricular assist devices (cf-LVADs).
Interestingly, this hemostatic abnormality associated with severe AS is fully corrected on the first day after
surgery. For AvWS associated with cf-LVADs, it disappears quickly after removal of the device, strongly
suggesting that the device itself is responsible for the syndrome. It is widely believed that the supraphysiologic
shear stress and/or long exposure time in severe AS and cf-LVADs are responsible for the loss of HMWM.
Although the destruction of HMWM is believed to be a combination of mechanical and enzymatic cleavage, the
complete mechanism still remains unclear. Also notable is that AvWS is rarely observed in pulsatile blood flow
devices. There is a need to understand the degradation mechanism of vWF and exposure time especially when
nonphysiologic blood flows are expected. The objective of this proposal is to characterize the degradation of
HMWM under fully controlled laminar through turbulent blood flow conditions in terms of power density
(energy dissipation rate per unit mass) and clinically relevant exposure times. The central hypothesis is that the
degradation of HMWM of vWF is a time-sensitive mechanoenzymatic event that occurs primarily under
turbulent flow conditions by exposing the ADAMTS13 to cleavage sites on vWF. Based on our previous
publications as well as evidence in the literature, we believe that the majority of vWF multimer degradation is
ADAMTS13 mediated. However, we recognize that there are other potential sinks and sources of vWF
including adsorption to the surfaces of a device, binding to platelets, and release of vWF from ⍺-granules of
activated platelets. We will test and account for these sinks and sources in these experiments. Successful
completion of the proposed study will allow us to i) determine the relationship between nonphysiologic blood
flow and exposure time involved in the loss of HMWM in cf-LVADs, ii) evaluate the degradation mechanism
of HMWM, and iii) characterize the mechanism in terms of mechanoenzymatic, mechanistic, and enzymatic
sensitivity through comprehensive vWF biology. Ultimately, the prospective model is expected to be a tool for
device design optimization leading to a next-generation blood pump and better clinical outcomes for patients
with AvWS.

Public health relevance
PROJECT NARRATIVE Degradation of high molecular weight multimers of von Willebrand factor leading to acquired von Willebrand syndrome (AvWS) is still a primary complication in using the continuous-flow blood pumps. In this study, we will characterize the degradation mechanism of the protein in terms of mechanoenzymatic, mechanistic, and enzymatic sensitivity through comprehensive vWF biology and fluid dynamics. The outcome will be used to develop a model to be a tool for device design optimization leading to a next-generation blood pump and better clinical outcomes for patients with AvWS.